Evaluation of CRAG screening with enhanced antifungal therapy for asymptomatic CRAG-positive persons

Dr. Rajasingham is an Assistant Professor in the Division of Infectious Diseases & International Medicine at
the University of Minnesota. Her long-term goal is to become an independent investigator with expertise in
evaluating the effectiveness and cost-effectiveness of innovative diagnostics and therapeutics related to the
prevention and management of AIDS-related opportunistic infections. She is particularly interested in using
cost-effectiveness analysis alongside clinical trials, in order to translate effective interventions into policy.
Training: This K23 award will provide the mentored clinical research experience and didactic training in
decision analysis and simulation modeling necessary to establish her independent research career. With the
mentorship of an interdisciplinary team with expertise in decision analysis, biostatistics, and HIV international
clinical trials, she will: 1) acquire advanced training in decision analysis and simulation modeling, 2) acquire
expertise in HIV international clinical research methodology, and 3) develop multidisciplinary collaborative and
networking skills.
Research: Cryptococcus is a leading cause of AIDS-related morbidity and mortality worldwide.
Cryptococcal antigen (CRAG) can be detected in the blood weeks to months prior to the onset of meningitis
and is an independent predictor of mortality. A public health strategy to reduce mortality is to screen for CRAG
in the plasma of people entering HIV care with a CD4 count <100 cells/mcL. Those who are asymptomatic
CRAG+ can be treated preemptively with fluconazole antifungal therapy to prevent meningitis or death while
receiving HIV therapy. Despite the survival benefit associated with this WHO-recommended CRAG screening
and treatment strategy, ~30% of asymptomatic CRAG+ persons die despite standard of care treatment with
fluconazole. Those with high CRAG titers (>1:160) are 3 times more likely to die than are those with low CRAG
titers (<1:80) in blood. I hypothesize that customized antifungal therapy based on CRAG titers will improve
survival, whereby patients with high titers (>1:160) require more aggressive antifungal therapy.
The overall objective of this proposal is to identify a more clinically effective yet economically feasible
treatment strategy for asymptomatic CRAG+ persons. The aims of this proposal are to: 1) determine if
enhanced antifungal therapy improves 6-month survival for asymptomatic persons with high CRAG titers; 2)
determine the cost-effectiveness of enhanced antifungal therapy for HIV-infected CRAG+ persons, stratified by
CRAG titer; and 3) validate a novel semi-quantitative CRAG lateral flow assay to rapidly detect high CRAG
titers (>1:160). The proposed study seeks to improve the international standard of clinical care for HIV-infected
persons with advanced disease, and to generate evidence that will inform international HIV care guidelines.
The findings and the training in decision analysis that Dr. Rajasingham will obtain will inform future proposals
to evaluate cost-effective strategies to reduce AIDS-related deaths across sub-Saharan Africa.

Public health relevance
Cryptococcal meningitis is a leading cause of AIDS-related deaths worldwide and can be prevented by screening for cryptococcal antigen (CRAG) in the blood before onset of meningitis symptoms. CRAG screening and preemptive treatment per WHO recommendations improves survival, though 30% of CRAG+ persons still die despite preemptive treatment. The objective of this study is to identify a more clinically effective treatment strategy for asymptomatic CRAG+ persons that is also cost-effective.